EFFECTS OF AEROBIC EXERCISE ON BLOOD GLUCOSE LEVELS AND PHYSICAL FITNESS

The purpose of this study is to confirm the hypothesis that aerobic exercise increases physical fitness and enhances blood glucose control without any adverse perinatal outcome.